Targeting Replication Stress and DNA Damage Response in Uterine Cancer

PROJECT SUMMARY
Uterine cancer (UC) incidence and death rates are both significantly increasing in the United States. Most UCs
are endometrial cancers which arise from the inner lining of the uterus and are defined by several different
histologic subtypes, the most common of which is endometrioid. Additionally, survival outcomes are worse for
black women. Because of the worsening survival of women with advanced and relapsed endometrial cancer,
this P01 grant is focused on targeting replication stress (RS) in order to improve therapeutic outcomes in these
patients. RS is defined as the slowing or stalling of the replication fork progression during DNA synthesis and is
widely recognized as a significant cause of genomic instability and a critical feature of cancer cells. This P01
grant investigates 3 different strategies for targeting RS in UC with the goal of translating these into effective
salvage therapies for women with advanced/relapsed UC. We have assembled a team of internationally
recognized researchers from the Dana-Farber Cancer Institute and the Brigham and Women’s Hospital, both in
Boston MA, with multidisciplinary expertise in UC, DNA repair and RS, immunotherapy, preclinical models,
biostatistics, computational biology, gynecologic pathology, drug development and clinical trials. This P01 grant
is being led by Drs. Panagiotis Konstantinopoulos, Joyce Liu, and Ursula Matulonis who are recognized
international leaders in the field of gynecologic cancer and endometrial cancer research.
This P01 grant consists of 3 Projects and 4 Cores. The leadership team for each Project is comprised of paired
investigators with complementary expertise in basic science and clinical/translational research. Project 1 focuses
on studying the mechanism of WEE1 inhibition in recurrent USC or p53-mutated UCs and the correlation of
WEE1 activity with functional and immunohistochemical (IHC) measures of RS. Based upon the results of a
clinical trial of the WEE1 inhibitor adavosertib which previously demonstrated significant clinical activity in USCs,
this project leverages a collection of patient-derived xenografts (PDXs), patient-derived organoids (PDOs), and
genetically engineered mouse models (GEMMs) of p53-mutated/null endometrial cancer to examine the effects
of WEE1 inhibition on functional and IHC measures of RS in the in vitro and in vivo setting. Additionally, through
a biopsy-driven investigator-initiated protocol of the WEE1 inhibitor ZN-c3 in USC, Project 1 will examine the
effects of WEE1 inhibition on measures of RS in co-clinical PDOs and correlation of these measures with clinical
activity. Project 2 focuses on the hypothesis that inhibition of the PI3K pathway can increase RS and therefore
create synergy with ATR inhibitors. In previously performed PRISM and CRISPR screens, inhibition of PI3K
signaling together with ATR inhibition was identified as potentially synergistic and subsequent experiments have
demonstrated synergism between the PI3K inhibitor copanlisib and the ATR inhibitor elimusertib. Project 2 will
examine in PDX, PDO, and GEMM model systems the potential for synergy between ATR and PI3K inhibition
and will explore the clinical activity of this combination in a Phase 1b dose escalation clinical trial with dose
expansion in uterine serous and ARID1A mutated uterine tumors, both enriched in concomitant PI3K pathway
alterations and genomic alterations associated with high RS. Project 3 focuses on further investigating
preliminary data showing that targeting the RS response through inhibition of DNA damage checkpoint kinases
ATR and WEE1 leads to increased DNA damage and activation of the STING/TBK1/IRF3 pathway, resulting in
enhanced anti-tumor immunity and improved response to immune checkpoint inhibition (ICI). Based on these, a
novel strategy is proposed to extend the benefit of immunotherapy in mismatch repair proficient (MMRP) cancers
by using DNA damage checkpoint kinase inhibitors in combination with ICIs. The main hypothesis is that priming
the immunologically “cold” MMRP UCs into “hot” tumors using DNA damage checkpoint kinase inhibition,
combined with ICIs to overcome tumor-mediated immunosuppression, will lead to effective antitumor immunity
against MMRP UCs. The 4 Cores in this grant include Administrative; Biostatistics and Computational Biology;
Preclinical Model Systems; and Pathology. Review of our P01 grant external to the Project and Core teams will
occur through an External Advisory Board (EAB), an Internal Advisory Board (IAB), and an advocate core.

Public health relevance
Project Narrative Because of the worsening survival of women with advanced and relapsed endometrial cancer, this P01 grant is focused on targeting replication stress (RS) in order to improve therapeutic outcomes in these patients. Each of the 3 projects focuses on different strategies for targeting RS in endometrial cancer: i) using WEE1 inhibition as monotherapy against uterine serous carcinomas (USC) and other p53-mutated uterine cancers characterized by genomic alterations associated with high RS; ii) using combined ATR and PI3K inhibition to capitalize on concomitant PI3K pathway alterations and genomic alterations associated with high RS in USCs and ARID1A mutated uterine carcinomas; and iii) using ATR and WEE1 inhibitors in combination with immune checkpoint inhibitors to facilitate effective anti-tumor immunity in this disease.